Technologies enabling robust closed-loop manufacturing of human pluripotent stem cell-derived cardiomyocytes

PROJECT SUMMARY
Cell therapy is a rapidly growing field, with Chimeric Antigen Receptor T (CART) cells and stem cell-based
therapies showing remarkable efficacy in treating hematologic cancers and regenerating tissue for conditions
like Parkinson’s Disease, blindness, type 1 diabetes, and heart failure. However, manufacturing cellular therapies
is complex, resulting in high costs and variable product quality. This study aims to address these challenges by
developing feedback-controlled closed-loop processes for differentiating human pluripotent stem cells (hPSCs)
into cardiomyocytes (CMs).
Despite advancements in hPSC-CM differentiation processes over the past decade, enabling their adoption
in various applications, including human development studies, disease modeling, drug screening, and clinical
trials for heart failure treatment, significant variability exists between batches and cell lines during manufacturing.
This variability becomes more pronounced with the transition from 2D to 3D platforms. Building on preliminary
data comparing successful and failed hPSC differentiation batches that identified genetic and epigenetic features
predictive of CM generation, notably variations in WNT and MAPK signaling in cardiac progenitor cells (CPCs),
this study aims to develop control strategies to enhance differentiation reproducibility across various conditions.
This project's overarching goal is to improve the robustness and reproducibility of hPSC differentiation into
CMs through feedback-controlled closed-loop manufacturing processes. Leveraging single-cell transcriptomics
and epigenomics, our project will gain a deep understanding of differentiation failure modes, enabling early
identification and correction of process deviations. The proposed aims are:
Aim 1: Identify 2D CM differentiation failure modes through integrated single-cell transcriptomics and
epigenomics. Single-cell RNA sequencing (scRNAseq) and transposase-accessible chromatin sequencing
(ATACseq) performed throughout CM differentiation runs and analysis of cell trajectories will identify key points
of deviation from differentiation and predict mechanism leading to off-target cell-type generation.
Aim 2: Develop 2D closed-loop CM differentiation processes and evaluate their robustness compared
to standard protocols. We will build genetic and epigenetic sensor hPSC lines to monitor gene expression and
chromatin accessibility at the single-cell level, test modulation of cardiac developmental pathways to rescue low
efficiency CM batches, and compare the robustness of closed-loop processes to standard protocols.
Aim 3: Develop scalable, 3D closed-loop CM differentiation processes and assess process variability.
Utilizing a 3D bioreactors for CM manufacturing, we will compare failure modes in 3D to 2D differentiation,
develop cell sensors and processes to modulate developmental signaling pathways, and increase the reliability
of CM production in scalable manufacturing platforms.

Public health relevance
PROJECT NARRATIVE This project strives to improve effectiveness and accessibility of cell therapies by advancing process to manufacture cells in a more reliable and less expensive manner. Using human pluripotent stem cell-derived cardiomyocytes as a testbed, we will use single cell molecular profiling of cell state transitions during manufacturing to identify failure points during manufacturing and to develop ways to correct these failures. We develop new feedback-controlled processes to manufacture cardiomyocytes in both 2D and 3D bioreactors, advancing efforts to use these cardiomyocytes in drug development and as therapies to treat heart disease.